Genetic Biocontainment Switch to Improve the Safety of Drug Detoxifying Bacteria in Preventing Chemotherapy-induced Diarrhea

PROJECT SUMMARY
Bioengineered microbes are a promising strategy to develop live biotherapeutic products that can
introduce novel metabolic activities into the gut microbiome and digestive system for the
prevention and treatment of several gut-related diseases/disorders. Sanarentero is developing
novel drug detoxifying bacteria (DDB), which is a bioengineered live biotherapeutic product that
can detoxify gut-toxic drugs causing chemotherapy-induced diarrhea in cancer patients.
Successfully addressing a major biosafety concern (i.e., the transmission of genetically modified
microbes into humans and environments) will make our product much more competitive since it
will improve clinical adaptability and aid the regulatory approval of our product. Towards improving
the safety profile of DDB, we are introducing a genetic biocontainment switch in our product that
can be triggered to contain the engineered metabolic function as and when needed. Our unique
genetic biocontainment switch (GBS) not only is designed to prevent the engineered metabolic
pathway genes to escape from a designated environment but also performs its function without
killing the microbes to minimize the cellular burden and genetic instability. The overall goal of the
project is to establish the activity and safety of drug detoxifying bacteria equipped with the
proposed genetic biocontainment switch (DDB_GBS) in an animal model. To achieve this goal,
the three specific aims of this phase 1 STTR proposal are 1) to bioengineer genetic
biocontainment switch into DDB; 2) to develop a delayed-release formulation of DDB_GBS
for improved intestinal engraftment; and 3) to evaluate the safety, glycosylation function, and
biocontainment efficiency of DDB_GBS. The success of this project is the proof-of-
concept evidence of our approach for developing novel drug detoxifying bacteria with a safety
feature that can detoxify cancer chemotherapeutic drugs in the gut environment
towards preventing chemotherapeutic-induced diarrhea in cancer patients. Once the
biocontainment efficiency of DDB_GBS is established, we will work on establishing the
preclinical efficacy and manufacturing scale-up in the GMP facility for a phase II SBIR proposal.

Public health relevance
PROJECT NARRATIVE This project develops a novel Genetic Biocontainment Switch for improving the safety profile of our drug detoxifying bacteria, currently under development for preventing chemotherapy-induced diarrhea in cancer patients. Our innovative biocontainment switch is designed to remove the engineered metabolic function without killing the bacteria, such that the commensal bacteria is returned to its native state in the gut microbial environment once the treatment is over. The project will develop proof-of-concept preclinical evidence of the delivery of engineered bacteria to the lower intestine, engraftment of bacteria, and efficiency of the genetic biocontainment switch.